Deciphering the role of CX3CR1 in Modulating Mechanisms of Amyloid driven Neurodegeneration in Alzheimer's Disease (Diversity Supplement)

The amyloid-cascade hypothesis states that deposition of extracellular Aβ plaques is the primary event in AD
that facilitates accumulation of hyperphosphorylated tau (pTau), formation of neurofibrillary tangles (NFTs) and
drives subsequent neurodegeneration. Microglial activation is the earliest response to pathological
changes in the brain and is known to shape neuronal activity and immune activation of neighboring
glial cells. Thus, how Aβ-driven microglial activation shapes neurodegenerative signaling in AD is a
critical unknown in current therapeutic approaches. Communication between microglia and neurons via
microglial CX3CR1 and its neuronal ligand is a central signaling checkpoint that shapes the immunological
niche in AD. RNA sequencing studies have postulated that downregulation of microglial CX3CR1 is a
neuroprotective response. By contrast, our data suggests that the loss of CX3CR1 increases accumulation of
toxic, soluble Aβ species which correlate with increased synaptic dysfunction, pTau pathology and
neurodegeneration. Indeed, recent reports have associated CX3CR1-V249I, a mutation which impairs
CX3CR1 function, with increased NFT pathology and worsened neurodegeneration in AD patients. This
proposal aims to test the unique hypothesis that downregulation/loss of CX3CR1 signaling alters microglial
activation and results in impaired clearance and/or increased accumulation of neurotoxic soluble Aβ oligomers.
Enrichment of toxic Aβ in the micro-environment triggers a cascade of neurodegenerative signaling including
the generation and spread of neurotoxic species of pTau. Using the single-nuclei sequencing approach we
propose an unbiased genetic screen to assess how CX3CR1 alters neurodegenerative, phagocytic and
neuroinflammatory signaling in early vs. late stages of AD. Results of this broad genetic analysis will be
validated by a deep pathological phenotyping of the disease using 5xFAD and APPPS1 transgenic AD mice
deficient in CX3CR1 signaling (Aim 1). To investigate how a toxic Aβ milieu in the absence of CX3CR1 can
drive neurodegeneration, we will assess the propagation and spread of pathological tau species following
stereotaxic injection of toxic tau from post-mortem AD tissue into the brains of 5xFAD mice with and without
CX3CR1 (Aim 2). Lastly, to understand how the human V249I variant affects neurodegenerative responses,
we will use CRISPER-Cas9 technology to generate human iPSC derived microglia with CX3CR1 harboring the
V429I (loss-of-function) mutation and isogenic iPS-derived AD neurons expressing M146L and L286V
mutations in the PSEN1 gene. Co-culture of human-derived microglia with isogenic AD neurons will be used to
assess a) how the V249I mutation shapes Aβ driven neurotoxic microglial activation and b) how Aβ-activated
V249I+ microglia alter neuronal activity and affect neurodegenerative signalling/pathology (Aim 3). Combining
the use of transgenic AD mouse models and human iPSC based in-vitro assays, this proposal will shed light on
the overarching effects of CX3CR1 on Aβ-driven neurodegeneration in the cascade of AD pathogenesis.

Public health relevance
Project Narrative Although the central hypothesis in AD states that deposition of amyloid-β (Aβ) plaques is the primary event that facilitates subsequent neurofibrillary tangle (NFT) pathology and neuronal loss, there is no clear understanding of the mechanisms of Aβ-driven neurodegenerative signaling. This proposal aims to investigate how microglial CX3CR1 signaling shapes the neurodegenerative milieu by triggering the accumulation of toxic Aβ species which in-turn facilitate Aβ-driven neurotoxic mechanisms, including the propagation of neurotoxic tau. This study will have critical implications in designing therapeutic approaches to deplete toxic Aβ species in patients with prodromal AD/MCI to slow down or arrest long-term neurodegeneration and cognitive decline.